Mitigating Delirium with Fluvoxamine Treatment for Non-Cardiac Surgery (MD FluNCS): Feasibility Trials & Mechanistic Insights

ABSTRACT
The pathogenesis of postoperative delirium likely involves systemic inflammation, downstream
neuroinflammation, and altered synaptic plasticity reflected by elevations in IL-6 and electroencephalographic
(EEG) slowing. Furthermore, there are no known pharmacologic interventions for preventing postoperative
delirium. Fluvoxamine is an antidepressant that could suppress neuroinflammation through sigma-1 receptor
agonism. Fluvoxamine reduces prostaglandin synthesis and cytokine release from human blood. It is
concentrates in the brain and neuroprotective via sigma-1 receptors. It improves survival in sepsis animal models
and reduces clinical deterioration from COVID-19. Promise in the treatment of delirium is supported by a series
of case reports of fluvoxamine treating delirium in older adults and/or intensive care unit. It is not clear whether
suppressing neuroinflammation is a viable pathway towards mitigating delirium severity. Furthermore, it is
unclear whether fluvoxamine is a feasible pharmacologic intervention for mitigating delirium risk, given societal
stigma against antidepressants as well as side effects of nausea and potential drug-drug interactions. To
evaluate the safety and feasibility of a multisite investigation on perioperative fluvoxamine, we propose
Mitigating Delirium with Fluvoxamine Treatment for Non-Cardiac Surgery (MD FluNCS): Feasibility Trials
& Mechanistic Insights.
This work will enhance our understanding of core pathogenesis of postoperative delirium in a population at risk
for Alzheimer's disease and related dementias. With the rise in the aging population, we hope to provide an
intervention to mitigate risk as well as translatable theragnostic biomarkers and approaches for future precision
medicine. The investigation will lay the groundwork for a larger scale Phase 3 trial geared toward advancing
long-term goal of improving public health and quality of life for those at risk of postoperative delirium and related
sequelae.

Public health relevance
PROJECT NARRATIVE Postoperative delirium is a debilitating and potentially preventable neurological complication in aged adults at risk for Alzheimer's disease and related dementias. While there is currently no pharmacologic agent to prevent delirium, fluvoxamine is an antidepressant that may reduce systemic and neuroinflammation involved in the pathogenesis of this costly disorder. The proposed investigation will establish biological plausibility and infrastructure required for a multisite clinical trial evaluating the repurposing of fluvoxamine to mitigate delirium risk and potential progression of long-term cognitive decline towards Alzheimer's disease.